Structural Determination of Novel GPCR Signaling Complexes that Mediate Sustained G Protein Signaling

ABSTRACT: Seven transmembrane receptors (7TMRs), alternatively known as G protein-coupled receptors
(GPCRs), are involved in the signaling and regulation of many physiological processes. Currently, over one third
of all clinically approved drugs target GPCRs, including the β-adrenoceptors (β-ARs) and the arginine
vasopressin type 2 receptor (V2R), which are GPCRs of great cardiovascular significance. Thus, a better
understanding of different modes of GPCR signaling stands to greatly inform the drug discovery process for this
important class of receptor targets. Classically, agonist-bound active GPCRs binds to and activate the
heterotrimeric G protein (Gαβγ), leading to dissociation between the Gα subunit and the remaining Gβγ subunits.
This dissociation initiates the generation of second messenger molecules such as cyclic AMP (cAMP), which
propagate a wave of signaling that eventually leads to a physiological response. To attenuate G protein signaling,
GPCR kinases (GRKs) phosphorylate the C-terminal tail of GPCRs, allowing for the binding and activation of β-
arrestins (βarrs), which mediates receptor desensitization and internalization. However, recent works have
shown that some GPCRs engage in sustained G protein signaling from within internalized cellular compartments
(e.g. endosomes) after receptor internalization rather than staying desensitized. With data directly implicating
βarrs in mediating this phenomenon, we and others further show that the aforementioned mode of sustained G
protein signaling is potentially mediated by two distinct novel GPCR-transducer complexes: a GPCR–G protein–
βarr mega-complex (‘megaplex’), whereby a single GPCR directly engages and activates both G protein and
βarr, and a GPCR–Gβγ–βarr complex that subsequently forms after G protein dissociation. This observation is
inconsistent with the classical model of GPCR signaling described above, which states that βarr and G protein
binding to a GPCR is mutually exclusive. While the discovery of these complexes is well established, and
provides a potential explanation for sustained G protein signaling, the structural basis governing the interactions
of each complex component, and by extension how sustained signaling is mediated, remains to be elucidated.
Accordingly, this proposal aims to determine the structure of both the megaplex and the GPCR–Gβγ–βarr
complex, with the following aims: (1) To optimize megaplex purification and complex formation for cryo-EM
structural studies, (2) to investigate the effects of the GPCR–Gβγ–βarr complex on sustained G protein signaling,
and to obtain its structure by cryo-EM. Structural elucidation of these complexes translates directly into a better
understanding of this newly appreciated mode of sustained signaling, and will serve as the foundation for the
design of therapeutics that confers spatiotemporal control of signaling by GPCRs, such as those of
cardiovascular importance. In particular, our structural approach will generate atomic models of the complexes
of interest, which will serve as starting points for structure-based drug design.

Public health relevance
PROJECT NARRATIVE In the United States, over 630,000 Americans die every year from cardiovascular disease, making it the leading cause of death for both men and women, and accounting for almost one in four deaths. Some of the most important drugs used to treat cardiovascular disease target specific receptors embedded within the plasma membrane of the cell. In this study, we seek to elucidate at a molecular level a newly appreciated mode of prolonged signaling mediated by these receptors, knowledge that will lay the foundation for the design of more efficacious therapeutics used to treat cardiovascular disease, leading to improved health outcomes for patients.